Analysis of the Molecular Determinants of Regulatory Hierarchy of a Bacterial Sma

DESCRIPTION (provided by applicant): Small RNAs (sRNAs) have been propelled to the forefront of genetic research as their diverse roles in regulation of cellular processes have been recognized. sRNAs are crucial for development in higher organisms; in bacteria, sRNAs regulate responses to many environmental stresses. Bacterial sRNAs that require the RNA chaperone Hfq regulate the translation or stability of mRNA targets by base pairing-dependent mechanisms. The Hfq-dependent sRNA SgrS is essential in E. coli for the response to glucose- phosphate stress. SgrS represents a new paradigm for sRNA regulators in bacteria. Other characterized Hfq-dependent sRNAs are non-coding and function solely via base pairing with and regulating target mRNAs (riboregulation). SgrS performs riboregulation on mRNA targets, and additionally encodes a novel protein, SgrT. This proposal focuses on the riboregulation function of SgrS, which our preliminary data indicates is more evolutionarily conserved than the protein coding function. Preliminary microarray experiments identified 10 candidate SgrS target mRNAs and we provide further evidence that 3 of these are directly up- or down-regulated by base pairing with SgrS. Analysis of SgrS homologs and their putative targets suggests that SgrS:mRNA interactions are better conserved for some targets than others. Since regulation of multiple targets by a single sRNA is a common theme for both bacterial and eukaryotic sRNA regulators, we propose to use SgrS as a model to examine how regulation of multiple targets with different base pairing characteristics and affinities is coordinated. Experiments in Aim 1, will define the SgrS target regulon. In Aim 2, a high- throughput RNA footprinting approach will be used to map sRNA:mRNA interactions for all E. coli SgrS:mRNA targets and some homologous SgrS:mRNA pairs with predicted unique base pairing characteristics. These studies will demonstrate direct interactions between SgrS and its targets and define the molecular determinants of these interactions. In Aim 3, we will determine whether there is a mechanism for SgrS to prioritize regulation of targets when SgrS levels are limiting (i.e., establish a hierarchy). We will then alter base pairing interactions by mutagenesis and determine how these alterations affect the regulatory hierarchy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Since sRNAs from organisms from bacteria to humans are believed to regulate multiple targets by base pairing-dependent mechanisms, these studies are broadly relevant because they will enhance our understanding of basic characteristics of sRNA- mediated regulation. Studies of SgrS in particular are important since SgrS is the first member of a novel class of bifunctional sRNA regulators and therefore serves as a model for other similar sRNAs that will be identified in the future. Project Narrative Since sRNAs from organisms from bacteria to humans are believed to regulate multiple targets by base pairing-dependent mechanisms, these studies are broadly relevant because they will enhance our understanding of basic characteristics of sRNA- mediated regulation. Studies of SgrS in particular are important since SgrS is the first member of a novel class of bifunctional sRNA regulators and therefore serves as a model for other similar sRNAs that will be identified in the future. __SpecificAimsTextDelimiter__ Research Plan Small RNAs (sRNAs) have been propelled to the forefront of genetic research as their diverse roles in regulation of cellular processes have been recognized. sRNAs are crucial for development in higher organisms. In bacteria, sRNAs regulate responses to many environmental stresses. Bacterial sRNAs that require the RNA chaperone Hfq regulate the translation or stability of mRNA targets by base pairing-dependent mechanisms. The Hfq-dependent sRNA SgrS is essential in E. coli for the response to glucose-phosphate stress. SgrS represents a new paradigm for sRNA regulators in bacteria. Other characterized Hfq-dependent sRNAs are non-coding and function solely via base pairing with and regulating target mRNAs (riboregulation). SgrS performs riboregulation on mRNA targets, and additionally encodes a novel protein, SgrT. This proposal focuses on the riboregulation function of SgrS, which our preliminary data indicates is more evolutionarily conserved than the protein coding function. Preliminary microarray experiments identified 10 candidate SgrS target mRNAs and we provide further evidence that 3 of these are directly up- or down-regulated by base pairing with SgrS. Since regulation of multiple targets by a single sRNA is a common theme for both bacterial and eukaryotic sRNA regulators, we propose to use SgrS as a model to examine how regulation of multiple targets with different base pairing characteristics and affinities is coordinated. 1. Specific Aims Aim 1. Define the SgrS regulon. Preliminary data provides strong evidence for direct regulation of three mRNAs by SgrS. Microarray experiments and screens of a translational fusion library will be performed in order to define the full SgrS regulon. Candidate targets that emerge from these studies will be validated further to identify those most likely to be direct. The elucidation of the complete SgrS regulon will provide insight into the nature of glucose-phosphate stress and allow us to address how SgrS prioritizes regulation of multiple targets. Aim 2. Map molecular interactions between SgrS and target mRNAs using a novel application of high- throughput fluorescent footprinting. Even with genetic evidence to support a direct interaction between an sRNA and target mRNA, it is often difficult to computationally predict which specific base pairing interactions are crucial for regulation. There are few sRNA:mRNA interactions that have been definitively mapped and this lack of information impedes improvement of computational predictions. We will adapt a high throughput method that was previously used to map RNA secondary structure for use in mapping sRNA:mRNA interactions. Because the method is much less labor-intensive than traditional RNA footprinting, we will be able to map many more interactions than would otherwise be possible, including those between SgrS homologs and their cognate mRNA targets. These studies will enhance our understanding of SgrS and will also impact the broader field of sRNA research by elucidating the molecular determinants for base pairing between more sRNA:mRNA pairs and providing a new high throughput method that can be applied to studies of other sRNAs. Aim 3. Examine how base pairing characteristics establish a regulatory hierarchy. Protein regulators establish a hierarchy for regulation of multiple targets based primarily on location and affinity of DNA binding sites in the operator regions of target promoters. Many sRNA regulators, including SgrS, also regulate multiple targets, but it is not known if or how a hierarchy for regulation of these targets is established. We will monitor expression of all SgrS targets simultaneously (by qRT-PCR) under conditions where concentrations of SgrS and a competitor target mRNA are varied. The prediction is that at limiting SgrS concentrations, the base pairing characteristics of each SgrS:target pair will determine which targets are regulated first. These experiments will define the hierarchy for SgrS targets. Further experiments will manipulate the base pairing characteristics and define how these changes alter the hierarchy. These experiments will shed light on the physiology of glucose-phosphate stress by defining the targets that are regulated most strongly and immediately when the stress signal is sensed. Furthermore, the experiments described will define how the base composition and extent of complementarity in the base pairing region influence regulation.